Formation of Retinyl-Opsins by Retinyl Formate as Molecular Shades Against Light-Induced Retinal Damage

Project Summary/Abstract
Stargardt disease (STGD1) is the most common form of inherited juvenile macular degeneration. STGD1 is
caused by autosomal recessive mutations in the ABCA4 gene, which encodes a membrane transporter that
removes all-trans-retinals (atRALs) from photoreceptors as part of the retinoid cycle. Free atRALs or their
bisretinoid condensation products promote photo-oxidative damage to the macula as seen in STGD1. The
same atRAL-mediated damage can also be seen in age-related macular degeneration (AMD), which is
expected to affect at least 18 million Americans by 2050. The production of atRAL starts at the level of opsin
proteins, which reside within photoreceptor outer segment disc membranes. Light is captured by opsin-
chromophore complexes, or visual pigments, causing their native bound chromophore, 11-cis-retinal (11cRAL),
to be converted to atRAL and forming activated opsins. These activated opsins initiate phototransduction and
are eventually spontaneously hydrolyzed to apo-opsin and atRAL. Exposure to intense light causes
photoreceptor overstimulation and dangerously high levels of atRAL, potentially leading to photoreceptor
damage and loss. Recently, a chromophore analogue, retinyl formate (RF), was found to irreversibly bind apo-
opsin and form retinyl-opsins that can no longer form visual pigments with 11cRAL. These retinyl-opsins also
absorb light outside the visible light spectrum and do not subsequently release atRAL upon light absorption.
Thus, RF can potentially reduce the proportion of visual pigments in the retina and thereby reduce the atRAL
burden during periods of intense light exposure. Therefore, I hypothesize that RF can serve as a molecular
shade at the opsin level, providing long-lasting protection to photoreceptors from light-induced damage. In this
proposal, I will characterize the site of the retinyl modification on opsin by RF, distinguishing whether RF
binding is competitive or allosteric with 11cRAL. I will determine if and how retinyl-opsins also could initiate the
phototransduction cascade. To investigate its applicability to a pre-clinical model, I will study whether RF
treatment of an STGD1 mouse model provides neuroprotection to photoreceptors against intense light
exposure via formation of retinyl-opsins and reduction of retinal atRAL and determine the relative proportion of
retinyl-opsins and remaining natural visual pigments. This work thus serves as a proof-of-concept approach to
determining whether disabling a proportion of opsins with an irreversible inhibitor of visual pigment formation
could prevent light-induced damage to photoreceptors, and point to the development of future therapeutics and
interventions for STGD1 and AMD.

Public health relevance
PROJECT NARRATIVE Stargardt disease is the most common inherited macular degeneration in children that leads to progressive vision loss and eventually to legal blindness by age 50. The macular degeneration seen in Stargardt disease is caused by impaired clearance of toxic molecules that are released by light-sensitive opsin proteins found in photoreceptors when they capture light. In this proposal, I will investigate whether irreversibly blocking the ability of opsins to release these toxic species is a viable strategy to providing long-lasting protection to the retina from light-induced damage, and delay the onset and progression of macular degeneration in STGD1.